NIDCD NATIONAL TEMPORAL BONE RESOURCE REGISTRY

The purpose of this contract is to continue and further develop the NIDCD National Temporal Bone, Hearing and Balance Pathology Research Registry that serves as a national resource for both the public and the biomedical research communities to promote research on the pathology underlying diseases and disorders of hearing and balance.